RESEARCH PROJECT 1: DAQING WU

Docetaxel is the first-line chemotherapy for metastatic castration-resistant prostate cancer (PCa), the major
cause of PCa mortality. Unfortunately, in most cases, PCa develops chemoresistance and continues
progressing, which has no cure. We developed a novel phenotypic screen and discovered bromocriptine, an
approved non-oncology drug, as a potent and selective inhibitor of chemoresistant PCa cells. In preliminary
studies, we demonstrated that bromocriptine effectively induced cell cycle arrest and cell death in
chemoresistant PCa cells via dopamine D2 receptor-dependent and -independent mechanisms. In mouse
models, bromocriptine monotherapy was efficacious in suppressing the skeletal growth of chemoresistant
PCa. These exciting results support our hypothesis that bromocriptine is a novel and effective subtype-focused
precision therapy for chemoresistant PCa. Through this Research Project, we will investigate the mechanism
of action and preclinical efficacy of bromocriptine against chemoresistant PCa. Our main objective is to provide
solid preclinical evidence supporting bromocriptine as a safe, effective, and affordable care for chemoresistant
PCa. To do so, we propose two specific aims. In Aim 1, we will elucidate the mechanism of action of
bromocriptine in chemoresistant PCa cells and discover novel molecular targets of bromocriptine. In Aim 2, we
propose demonstrating that oral administration of bromocriptine is efficacious against chemoresistant PCa and
exhibits excellent safety profiles in preclinical models. With the successful accomplishment of this project,
bromocriptine will be well-positioned to be promptly repurposed as a safe, effective, and affordable
precision therapy for chemoresistant PCa subtypes. The impact of our research has significant public
health implications for improving PCa treatment, decreasing the mortality rate of PCa, and reducing PCa
disparity.

Public health relevance
Chemoresistant prostate cancer is lethal with no cure. This Research Project is to develop bromocriptine, an approved non-oncology drug, as a safe, effective, and affordable precision therapy for the subtypes of chemoresistant prostate cancer. Our drug repurposing approach will allow a prompt translation from bench research into bedside care of cancer patients, therefore having significant public health impacts.